Mapping inflammatory bowel disease variants to genes and functional phenotypes in human macrophages

Abstract
Inflammatory Bowel Disease (IBD) is a complex genetic disorder marked by dysregulated gut immune
responses to environmental factors, influenced by numerous genetic variants. Affecting over 0.7% of
Americans and millions worldwide, IBD's genetic and molecular underpinnings remain incompletely
understood. Although genome-wide association studies (GWAS) have successfully identified hundreds of IBD-
associated loci, the prioritization of regulated genes and their functional relevance in disease-relevant cells
remain unclear. This project seeks to fill these gaps by utilizing a large-scale CRISPRi Perturb-seq screen in
primary human monocytes, a key cell type in IBD pathogenesis.The specific aims of this proposal are to: (1)
elucidate the transcriptional consequences of IBD candidate genes in monocytes from diverse populations
using a GWAS-guided Perturb-seq approach, and (2) functionally characterize non-coding variants from East
Asian (EAS) IBD-associated loci. This innovative approach will identify key regulatory pathways and gene
programs involved in monocyte and macrophage function, and highlight potential ancestry-specific differences.
Furthermore, this study will improve understanding of how non-coding IBD-associated variants shape immune
responses by linking these variants to their target genes. In the mentored K99 phase, the research goal is to
map the genotype-phenotype landscape of IBD candidate genes in human monocyte-derived macrophages
and systematically link GWAS-nominated variants to their target genes. During the R00 phase, the focus will
shift to exploring the genetic effects on macrophage differentiation and immune responses within their native
tissue environment using in vivo Perturb-seq, with particular emphasis on genes identified during the K99
phase as key regulators of macrophage plasticity, and functionally characterizing select non-coding variants to
gain mechanistic insights into gene regulation. The short-term career goal is to complete the proposed
research, develop a multi-pronged pipeline for GWAS guided functional study, and receive multidisciplinary
training under the mentorship of Dr. Cho and a diverse advisory committee. The long-term career goal is to
lead a research lab focused on understanding how genetic variants contribute to dysregulated immune
responses in chronic inflammatory diseases, ultimately guiding the development of more precise and
personalized therapeutic strategies. The collaborative and resource-rich environment of the New York area
provides an ideal setting for achieving these goals.

Public health relevance
Project Narrative Inflammatory Bowel Disease (IBD) is a complex genetic disorder driven by dysregulated immune responses to environmental triggers, influenced by multiple genetic variants. Despite genome-wide association studies (GWAS) identifying hundreds of IBD-associated loci, the functional roles of many variants remain unclear. This project aims to prioritize genes linked to IBD risk variants and functionally investigate their roles in human macrophages, advancing our understanding of genetic regulation in IBD and guiding the development of targeted therapies.